Core--Biomathematics and Informatics

The specific aims of the Biostatistical and Informatics Core are: Aim 1: To provide the statistical, mathematical, and data management support required to accomplish the specific aim of the individual projects and cores. Aim2. To assist in the design and analysis of new projects and studies arising from the results of the proposed studies. Aim 3: To assist individual investigators and other Core facilities in the collection and management of required data. Aim 4: To facilitate the exchange of data and information between the separate data systems of the individual Projects and Cores. Aim 5: To establish and maintain a central data management system in which data pertaining to each study subject will be maintained and coordinated. Aim 6: To oversee quality control, security, confidentiality, and audit procedures.